The Epitranscriptome as a Novel Mechanism of Arsenic-Induced Diabetes.

PROJECT SUMMARY
The parent grant, entitled “The Epitranscriptome as a Novel Mechanism of Arsenic-Induced Diabetes”, aims to
investigate the impacts of low-level arsenic (As) exposure on the N6-methyladenosine (m6A)-epitranscriptome
and on diabetes in American Indian communities in the US. The parent study proposed to test the hypothesis
that altered m6A is plausible mechanism for As-related diabetes in the Strong Heart Study (SHS) cohort. Our
original proposal relied on immunoprecipitation-based sequencing methods that required large amounts of
RNA and were unable to profile m6A at the single base resolution. However, recent technological advances by
Oxford Nanopore Technologies (ONT) now allow for direct detection of m6A on RNA strands, improving RNA
input and providing invaluable information on transcript splicing and isoforms, along with other modifications to
RNA. We are requesting a supplemental award to enable the best possible science for our Aims, given the
rapid and significant changes in the chemistry, protocols, and informatics capacity of the direct RNA
sequencing methods. Specifically, in our hands, the latest flowcells and chemistry enable a dramatic increase
in accuracy (from 75% to 98%), new tools for calling base modifications (i.e. m6A) and better throughput.
However, the new flowcells and chemistry are more expensive, and would necessitate additional funding
beyond the parent award to enable processing of all the banked samples from our study with the best methods
for RNA modification detection and epitranscriptome mapping of environmental exposure.

Public health relevance
PROJECT NARRATIVE Increasing evidence supports the role epitranscriptomic mechanisms linking arsenic to diabetes and metabolic dysfunction in American Indian communities. Recent technological advances now allow for improved accuracy, detection and increased scientific information on epitranscriptomic modifications via direct RNA sequencing. This study can provide insight into novel pathways of arsenic related diabetes, identify prevention and interventions, and inform recommendations for arsenic levels.